PHASE I STUDY OF CYCLIC HPMPC IN HIV INFECTED PATIENTS

All subjects have completed drug dosing. Zidovudine levels are being analyzed. The drug does not appear to be orally bioavailable. Further study of other prodrugs of HPMPC are planned.